NEUROPLASTICITY/NEUROGENESIS, KEY FACTORS AFFECTING BRAIN HEALTH AND AGING

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Understanding the molecular and psychobiological factors of brain plasticity and adult neurogenesis that are relevant for brain health and aging.